Core 07: Clinical Research Resources Core

Project Summary: Clinical Research Resources Core
The Clinical Research Resources (CRR) Core met its goals in the second funding cycle by developing and
growing a multi-institutional research infrastructure and is now poised to grow further by deepening the
partnership with clinical trial units at three more institutions and by supporting multi-institutional grants across
the LA CaTS network. There are three Specific Aims for this next cycle defined as follows: Aim 1. Support
clinical activity and ensure efficient and effective data collection in ongoing clinical trials including the All of Us
study and the Long-COVID PASC/RECOVER trial. Aim 2. Expand support through development of infrastructure
and human resources for clinical and translational research at LSU Health Shreveport and the VA and UMC
hospitals in New Orleans. Aim 3. Enhance competitive clinical and translational research programs through
training and professional development. Specifically, we will add a new marketing, recruitment and retention focus
to our ongoing training activities. Aim 4. Extend the reach of CRR beyond the traditional clinical trial unit to
engage underserved and underrepresented populations within the state. Specifically, we will collaborate with
the Community Engagement and Outreach (CEO) Core to establish and maintain a network of disease-focused
community members in New Orleans, Baton Rouge, and Shreveport. Network members will be recruited through
CEO as well as Federally Qualified Health Centers and Agriculture Extension agents working with underserved
and rural populations. Accomplishment of these aims will significantly enhance the infrastructure for clinical
research in the State of Louisiana, leading to improved health outcomes and reduced health disparities for State
residents with chronic diseases such as cancer, obesity, diabetes, and COVID-19.